Cognitive Behavioral Effects on Sleep, Pain, and Cytokines in Gynecologic Cancer

DESCRIPTION (provided by applicant): Gynecologic cancers cause substantial morbidity and mortality among women. Developing, implementing, and disseminating interventions that reduce morbidity and mortality secondary to gynecologic cancers are a public health priority. To the extent that psychological factors may influence quality of life and tumor biology among women with gynecologic cancers, psychological interventions may represent an important adjunct to standard clinical care in this population. Among individuals with cancer, there is emerging evidence that stressors and psychological responses to stressors activate central and peripheral stress systems, resulting in downstream effects on the tumor microenvironment, e.g. hypothalamic-pituitary-adrenal (HPA) axis dysregulation, inflammatory/growth factor upregulation, that may favor tumorigenesis. Little is known about whether psychological interventions may modulate biobehavioral factors that may promote tumorigenesis among women with gynecologic cancer. This is a significant gap in the literature. Sleep quality, pain, and mood are three patient-centered outcomes that may represent important intervention targets for women with gynecologic cancers, as insomnia, pain, and negative mood states are (1) prevalent and (2) have been associated with HPA dysregulation and inflammatory/growth factor up regulation in this population in empirical research. The objective of this application is to examine cognitive behavioral therapy (CBT) intervention effects on patient- centered and physiological outcomes among women with gynecologic cancers undergoing adjuvant chemotherapy. Grounded within the Central Arousal Theory of Stress (CATS) and a biobehavioral model of tumor biology, the central hypothesis of this application is that a CBT intervention targeting insomnia and pain will (a) improve nighttime sleep patterns, pain, and negative mood states, and (b) reduce cortisol levels, normalize daytime cortisol rhythm, and reduce proinflammatory/proangiogenic cytokine levels in women with gynecologic cancers. If hypothesized relationships emerge, they will guide future research examining the extent to which CBT may impact long-term quality of life, response to cancer treatment, and length of disease- free interval/survival in women with gynecologic cancer. The proposed study will be implemented by a multidisciplinary team with research/clinical experience in psycho-oncology, psychoneuroimmunology (PNI), behavioral sleep medicine, pain, reproductive immunology, and gynecologic oncology. The proposed study is innovative in that it will (1) combine empirically-supported CBT techniques for insomnia and pain into a multicomponent intervention tailored for women with gynecologic cancers, and (2) examine CBT effects on central sensitization of pain among individuals with cancer using quantitative sensory testing (QST). The results of this research will be significant to public health initiatives, because although gynecologic cancers are among the leading causes of cancer-related death among women, there is a paucity of research examining the effects of psychosocial interventions on patient-centered and physiological outcomes in this population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Gynecologic cancers cause substantial morbidity and mortality among women. Developing, implementing, and disseminating interventions that reduce morbidity and mortality secondary to gynecologic cancers are a public health priority. In spite of this, there is a paucity of research examining the effects of psychosocial interventions on patient-centered and physiological outcomes in this population. To the extent that psychological factors may influence quality of life and tumor biology among women with gynecologic cancers, psychological interventions may represent an important adjunct to standard clinical care in this population. Gynecologic cancers cause substantial morbidity and mortality among women. Developing, implementing, and disseminating interventions that reduce morbidity and mortality secondary to gynecologic cancers are a public health priority. In spite of this, there is a paucity of research examining the effects of psychosocial interventions on patient-centered and physiological outcomes in this population. To the extent that psychological factors may influence quality of life and tumor biology among women with gynecologic cancers, psychological interventions may represent an important adjunct to standard clinical care in this population. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS A.1. Statement of the Problem Gynecologic cancers cause substantial morbidity and mortality among women. Developing, implementing, and disseminating interventions that reduce morbidity and mortality secondary to gynecologic cancers are a public health priority. To the extent that psychological factors may influence quality of life and tumor biology among women with gynecologic cancers, psychological interventions may represent an important adjunct to standard clinical care in this population. Among individuals with cancer, there is emerging evidence that stressors and psychological responses to stressors activate central and peripheral stress systems, resulting in downstream effects on the tumor microenvironment, e.g. hypothalamic-pituitary-adrenal (HPA) axis dysregulation, inflammatory/growth factor upregulation, that may favor tumorigenesis. Little is known about whether psychological interventions may modulate biobehavioral factors that may promote tumorigenesis among women with gynecologic cancer. This is a significant gap in the literature. Sleep quality, pain, and mood are three patient-centered outcomes that may represent important intervention targets for women with gynecologic cancers, as insomnia, pain, and negative mood states are (a) prevalent and (b) have been associated with HPA dysregulation and inflammatory/growth factor upregulation in this population in empirical research. The objective of this application is to examine cognitive behavioral therapy (CBT) intervention effects on patient- centered and physiological outcomes among women with gynecologic cancers undergoing adjuvant chemotherapy. Grounded within the Central Arousal Theory of Stress (CATS) and a biobehavioral model of tumor biology, the central hypothesis of this application is that a CBT intervention targeting insomnia and pain will (a) improve nighttime sleep patterns, pain, and negative mood states, and (b) reduce cortisol levels, normalize daytime cortisol rhythm, and reduce proinflammatory/proangiogenic cytokine levels in women with gynecologic cancers. This central hypothesis will be tested by pursuing the specific aims in A.2. If hypothesized relationships emerge, they will guide future research examining the extent to which CBT may impact long-term quality of life, response to cancer treatment, length of disease-free intervals, and length of disease-free survival in women with gynecologic cancer. The proposed study will be implemented by a multidisciplinary team with research and clinical experience in psycho-oncology, psychoneuroimmunology (PNI), behavioral sleep medicine, pain, reproductive immunology, and gynecologic oncology. The proposed study is innovative in that it will (a) combine empirically-supported CBT techniques for insomnia and pain into a multicomponent intervention tailored for women with gynecologic cancers, and (b) examine CBT effects on central sensitization of pain among individuals with cancer using quantitative sensory testing (QST). The results of this research will be significant to public health initiatives, because although gynecologic cancers are among the leading causes of cancer-related death among women, there is a paucity of research examining the effects of psychosocial interventions on patient-centered and physiological outcomes in this population. A.2. Specific Aims and Hypotheses Specific Aim 1. To examine the effects of a cognitive-behavioral intervention (CBT.i.p.) on nighttime sleep among women with gynecologic cancers for which adjuvant chemotherapy is the standard of care. Hypothesis 1. Women with gynecologic cancers undergoing CBT.i.p. will experience significant improvements in nighttime sleep (e.g., sleep onset latency, number of nighttime awakenings, wake time after sleep onset, sleep quality rating) at post-intervention compared to those in a wait-list control condition. Specific Aim 2. To examine the effects of CBT.i.p. on pain among women with gynecologic cancers for which adjuvant chemotherapy is the standard of care. Hypothesis 2a. Women with gynecologic cancers undergoing CBT.i.p. will experience significant improvements in clinical pain (i.e., pain severity, pain interference) at post-intervention compared to those in a wait-list control condition. Hypothesis 2b. Women with gynecologic cancers undergoing CBT.i.p. will experience significant improvements in central sensitization of pain (i.e., reductions in temporal summation of second pain) at post-intervention compared to those in a wait-list control condition. Specific Aim 3. To examine the effects of CBT.i.p. on negative mood states among women with gynecologic cancers for which adjuvant chemotherapy is the standard of care. Hypothesis 3a. Women with gynecologic cancers undergoing CBT.i.p. will experience significant reductions in depressive symptomatology at post-intervention compared to those in a wait-list control condition. Hypothesis 3b. Women with gynecologic cancers undergoing CBT.i.p. will experience significant reductions in anxious symptomatology at post-intervention compared to those in a wait-list control condition. Specific Aim 4. To examine the effects of CBT.i.p. on HPA functioning and circulating levels of proinflammatory and proangiogenic factors among women with gynecologic cancers for which adjuvant chemotherapy is the standard of care. Hypothesis 4a. Women with gynecologic cancers undergoing CBT.i.p. will experience significant reductions in serum cortisol and normalization of diurnal salivary cortisol rhythm at post-intervention compared to those in a wait-list control condition. Hypothesis 4b. Women with gynecologic cancers undergoing CBT.i.p. will experience significant reductions in proinflammatory cytokine levels (i.e., serum interleukin-1 [IL-1], IL-6, IL-8, and tumor necrosis factor [TNF]-α) at post-intervention compared to those in a wait-list control condition. Hypothesis 4c. Women with gynecologic cancers undergoing CBT.i.p. will experience significant reductions in proangiogenic cytokine levels (i.e., serum vascular endothelial growth factor [VEGF]) at post-intervention compared to those in a wait-list control condition. Specific Aim 5. To examine the indirect effects of CBT.i.p. associated improvements in nighttime sleep, pain, and negative mood states on HPA functioning and circulating levels of proinflammatory and proangiogenic factors among women with gynecologic cancers for which adjuvant chemotherapy is the standard of care. Hypothesis 5a. CBT.i.p. associated improvements in nighttime sleep, pain, and negative mood states will partially mediate the relationship between CBT.i.p. and modulations in HPA functioning. Hypothesis 5b. CBT.i.p. associated improvements in nighttime sleep, pain, and negative mood states will partially mediate the relationship between CBT.i.p. and reductions in proinflammatory cytokine levels. Hypothesis 5c. CBT.i.p. associated improvements in nighttime sleep, pain, and negative mood states will partially mediate the relationship between CBT.i.p. and reductions in proangiogenic cytokine levels. Note. The effects of CBT.i.p. will be tested within the context of important biobehavioral factors that could offer competing explanations for the effects of the intervention on outcomes.